BIOSYNTHESIS OF FACTOR VIII COAGULANT ANTIGEN

Several human hepatoma cell lines were previously studied for their ability to synthesize FVIII coagulant antigen. No FVIII coagulant antigen could be detected by immuno-precipitation of 35S metabolically labeled protein from these cells lines nor was any mRNA for FVIII coagulant antigen detectable by hybridization studies with a 32p labeled synthetic oligonucleotide probe for FVIII antigen by assaying conditioned media from a human "prophepatocyte: cell line provided by Dr. Paul Price, Hana Biologics. Immuno-radiometric assay of the conditioned media (and 10X concentrated conditioned media) showed no detectable FVIII antigen.